The Pacific Northwest Prostate Cancer SPORE

PROJECT SUMMARY/ABSTRACT
The Pacific Northwest (PNW) Prostate Cancer SPORE continuation grant represents a coordinated effort of four
institutions with established programs and strengths in translational prostate cancer research including basic,
clinical, and population sciences as well as career development: 1) the Fred Hutchinson Cancer Research
Center (FHCRC); 2) the University of Washington (UW) and its affiliated institutions; 3) the University of British
Columbia and the Prostate Centre of Vancouver General Hospital (UBC); and 4) Oregon Health and Science
University (OHSU). These Seattle-, British Columbia- and Portland-based institutions have large multidisciplinary
teams of investigators and laboratories dedicated to prostate cancer research and a history of working closely
together within this larger milieu. The respective teams of clinicians and researchers at these institutions bring
considerable scientific depth, breadth, creativity, and vision required for confronting the most challenging
problems blocking progress in our ultimate goal of reducing the morbidity and mortality associated with prostate
cancer. This SPORE proposal enlarges the blueprint for a well-built, distinctive and coordinated translational
prostate cancer research effort spanning the entire PNW.
All participating institutions have made substantial commitments toward supporting the SPORE and its
innovative, translational projects: 1) Molecular predictors of prostate cancer progression and mortality; 2)
Targeting Emergent Vulnerabilities in AR-Inactive Prostate Cancer; 3) Oncofetal Glycosaminoglycans as
Molecular Targets in Prostate Cancer; 4) Clinical Development of Therapeutic Strategies Targeting Damage
Repair; and 5) Exploiting mechanisms of response and resistance to next generation androgen pathway
antagonists. We also propose four Cores to support these projects: 1) Leadership and administration; 2)
Biospecimens; 3) Biostatistics and Data Analytics; and 4) Clinical research. In addition, we propose a
Developmental Research Program and a Career Enhancement Program that will significantly embellish and
strengthen the translational goals of our prostate cancer research program and expand opportunities for
engaging young as well as established investigators in our multidisciplinary environment.

Public health relevance
PROJECT NARRATIVE Prostate cancer (PC) is a major cause of cancer incidence and mortality in US men. This year alone 180,000 men will be diagnosed and 26,000 will die of the disease; and worldwide, the annual number of men dying from PC is increasing. This highlights the urgent need for translational PC research to uncover the underlying genetic and genomic factors and pathways that drive PC toward its lethal phenotype, including resistance to therapy.